S. aureus COG0523s as bacterial zinc metallochaperones critical to pathogenesis

PROJECT SUMMARY/ABSTRACT
Staphylococcus aureus is an opportunistic pathogen that is critical to public health and a top cause of infectious
death worldwide. To infect humans and cause disease, S. aureus is dependent on the availability of nutrient
metals, including zinc (Zn). In response to infection, host factors including the S100 protein calprotectin (CP) act
as effectors of nutritional immunity and sequester nutrient metals. Vertebrate proteins of the COG0523 family
have been identified as bona-fide Zn metallochaperones that equip downstream metalloprotein effectors with Zn
ions. COG0523s in bacteria are predicted to perform a similar role in maintaining cellular metal homeostasis and
supporting cellular function, particularly in the setting of Zn starvation. This proposal aims to evaluate S. aureus
COG0523 orthologs crzA and zigA, define the impact that these genes have on pathogenesis, and elucidate
their role in Zn transfer to predicted interaction partners. Preliminary data suggest that crzA and zigA are
regulated by Zn via the transcriptional repressor Zur, that high confidence interaction partners exist for both CrzA
and ZigA, and that loss of either COG0523s or predicted binding partners increases sensitivity to DNA damage.
This phenotype is pronounced in crzA and zigA mutants exposed to both Zn stress and specific DNA damage.
The central hypothesis of this proposal is that S. aureus COG0523s transfer Zn to metalloproteins
involved in DNA damage repair in a Zn- and GTP-dependent manner and that this process is important
to S. aureus pathogenesis. To test this hypothesis, biochemical, genetic, and microbiological techniques will
be used to define a model of CrzA and ZigA function in S. aureus. In Aim 1, I will define the mechanism for
interaction between COG0523s and their clients and evaluate how metal, candidate clients, and GTP/GDP affect
the dynamics of CrzA and ZigA Zn transfer. To accomplish this, I will express and purify COG0523s and their
clients, and define the function and required co-factors of ZigA and CrzA by co-immunoprecipitation, client-
specific biochemical assays, and inductively coupled plasma mass spectrometry (ICP-MS). In Aim 2, I will test
the hypothesis that COG0523s regulate client activity and affect S. aureus DNA maintenance and that conserved
COG0523 Walker and CXCC motifs are required for ZigA and CrzA function in S. aureus. I will conduct growth
curves and survival assays in the presence of DNA damaging agents and in bone-marrow derived macrophages
to elucidate the impact of Zn, DNA damage, COG0523s, and the metal/GTP-binding motifs of these proteins on
S. aureus growth and mutagenesis. In Aim 3, I will test the hypothesis that CrzA and ZigA enable S. aureus to
circumvent host-imposed Zn restriction. Manipulation of Zn-handling both in the host and pathogen will
demonstrate the impact of COG0523s on infection and increase the rigor of our approach. Taken together, the
proposed work will have broad implications for the study of S. aureus pathogenesis. This work has the potential
to establish CrzA and ZigA as the first experimentally confirmed bacterial Zn-metallochaperones and continue
to develop an understanding of the role of nutritional immunity in therapeutics and clinical practice.

Public health relevance
PROJECT NARRATIVE Staphylococcus aureus is a Gram-positive pathogen that relies on nutrient metals to respond to stress and cause infections. The proposed research will define the importance of zinc during S. aureus pathogenesis by determining the function of two putative metallochaperones CrzA and ZigA that we hypothesize bind and activate zinc-dependent S. aureus proteins implicated in DNA maintenance and DNA damage repair. The proposed work will establish the importance of CrzA- and ZigA-dependent metal allocation during the pathogenesis of infection and establish the regulation of DNA repair as a target for the development of new anti-microbial agents.